Structural mechanisms of Scap/SREBP signaling in membrane homeostasis

Project Summary/Abstract
The goal of this project is to understand at the molecular level how cholesterol exerts negative feedback on its
own biosynthesis in mammalian cells. Cholesterol is an essential lipid, both serving as a basic building block of
cellular membranes and acting as a precursor for steroid hormones. We seek to understand the atomic structures
and mechanism of the membrane proteins Scap and Insig, which control SREBP processing and thereby
regulate cholesterol biosynthesis. Scap binds to the SREBP transcription factors and controls their maturation
in a cholesterol-dependent manner. Insig binds to Scap when cholesterol levels are high and helps to retain
Scap and SREBPs in the endoplasmic reticulum (ER), whereas the COPII adapter proteins Sec23/24 binds to
Scap when cholesterol levels are low and promotes trafficking to the Golgi apparatus. We use structural biology
and biophysical tools to understand at the atomic level how Scap and Insig respond to membrane cholesterol
and regulate SREBPs. Our previous work exploited the chicken orthologs of Scap and Insig, as well as a
mutation that locks Scap into a cholesterol bound-like state. In these studies, we elucidated a major
conformational rearrangement of Scap's transmembrane architecture and ER luminal loop that is stabilized by
Insig binding, and therefore presumed to be promoted by high cholesterol. However there are still no structures
of Scap/Insig bound by cholesterol itself, to explain how the lipid influences Scap's conformational equilibrium.
We will use single-particle cryo-EM methods to elucidate the high-resolution structure of the mammalian
Scap/Insig complex bound to cholesterol. Mutagenesis and SREBP functional studies will be used to probe and
validate the importance of different bound cholesterol molecules in SREBP regulation. Further we will carry out
purification and cryo-EM structure determination of the Scap/Insig complex in the presence of different small
molecules that have been proposed as Scap inhibitors. These structures will show how drugs can interact with
this ER membrane protein complex to modulate SREBP signaling, and elucidate whether their binding modes
overlap with the natural ligand cholesterol. When membrane cholesterol is low, Scap/SREBP complexes are
trafficked to the ER through Scap's interaction with COPII. Determining the structure of the Scap/COPII complex
is challenging due to the low affinity of this interaction, and no such cargo/COPII complexes have yet been
structurally characterized. We will use yeast display selections to isolate nanobodies that stabilize the
Scap/COPII complex, and use these reagents to purify the complex in detergent for single-particle cryo-EM
analysis. The structure of this complex will show how COPII recognizes Scap's cytosolic surface under low-
cholesterol conditions, and further indicate how the interaction depends on the low-cholesterol conformation of
Scap. Overall, our molecular dissection of the Scap/SREBP signaling system will show how cholesterol
homeostasis is maintained at the atomic level, and provide a framework for future therapeutic development
targeting this pathway in metabolic diseases.

Public health relevance
Project Narrative The goal of this project is to understand at the molecular level how cholesterol, an essential lipid, exerts negative feedback on its own biosynthesis in mammalian cells. We will use biophysical techniques to elucidate the structural basis for the interaction between cholesterol and its regulatory protein Scap, and also determine how Scap interacts with the cellular membrane trafficking machinery to promote biosynthesis under low cholesterol conditions. These combined efforts will benefit public health, since disrupted cholesterol metabolism is a common feature of human diseases and Scap is a potential therapeutic target for metabolic disorders such as fatty liver disease.